Identification of sequences and factors required for HbF repression

? DESCRIPTION (provided by applicant): The level of fetal hemoglobin (HbF) is a key modifier of the clinical severity of the β-hemoglobin disorders sickle cell disease and β-thalassemia. The goal of this proposal is to identify mechanisms that regulate HbF level and could serve as rational targets for efforts to re-induce HbF for the β-hemoglobin disorders. Genome- wide association studies (GWASs) have identified BCL11A as a critical HbF-associated locus. Functional studies have demonstrated that BCL11A is a bona fide repressor of γ-globin transcription. Naturally occurring common genetic variation modulates an erythroid-specific enhancer of BCL11A. Our prior studies identified the GWAS-marked erythroid enhancer of BCL11A as the substrate for common genetic variation associated with HbF level. Genome editing has revealed critical sequences within this enhancer required for HbF repression in the adult stage. I hypothesize that these sequences recruit critical trans-acting factors, which themselves are required for suppressing HbF levels. In addition, I hypothesize that other critical sequences at the BCL11A and HBS1L-MYB loci are required to repress HbF in the adult-stage. To test these hypotheses, I will: (1) utilize a high-resolution, high-throughput genome editing approach to identify non-coding sequences at BCL11A and HBS1L-MYB associated with HbF level; and (2) define trans-acting factors that physically and functionally interact with critical on-coding sequences at BCL11A and HBS1L-MYB. I expect that accomplishment of these aims will not only deepen our current understanding of cis- and trans-acting determinants of developmental regulation of globin gene expression but also yield novel insights to guide therapeutic efforts for HbF re-induction.

Public health relevance
PUBLIC HEALTH RELEVANCE: The β-hemoglobin disorders sickle cell disease and β-thalassemia are severe inherited blood diseases affecting millions of individuals worldwide. BCL11A and HBS1L-MYB are genetic loci that determine the level of fetal hemoglobin, which in turn can ameliorate the β-hemoglobin disorders. In my previous work, I have identified novel mechanisms by which common genetic variation affects regulatory regions of the BCL11A gene. In this proposal, I seek to: (1) extend my previous work to identify additional critical regulatory sequences at BCL11A and HBS1L-MYB; and (2) characterize transcription factors that control these critical sequences. These results will be of vital relevance for the design of novel therapeutic strategies for the β-hemoglobin disorders